A Single-Cell Transcriptome Atlas for Zebrafish Development

The Problem: Different diseases affect different cell types, each defined by its unique set of expressed
genes: its transcriptome. Single cell transcriptome sequencing (scRNA-seq) is a powerful way to identify
cell types in health and disease by identifying clusters of cells that share similar transcriptomes. scRNA-
seq methods, however, generally dissociate samples, thus losing information about where each cell
cluster resides in the body. To learn where each cluster resides in an intact animal, the best current
method is in situ hybridization to whole mounts or tissue sections. The problem is that traditional in situ
hybridization protocols seldom achieve sufficient resolution to locate rare cell types in the body. The
solution is Single molecule Fluorescent In Situ Hybridization (smFISH), a method to detect and count
specific individual RNA molecules inside cells.
The Specific Aim of this Administrative Supplement request is to purchase a Keyence BZ-X800E
fluorescence microscope to enable smFISH experiments. This equipment will more effectively achieve the
aims of the parent grant within the scope of the funded project. Proposed work does not overlap with
funded work in the parent award because we cannot perform smFISH effectively without the requested
equipment.
This supplement request aligns with the parent grant’s main goals: to develop a single-cell
transcriptomic atlas for zebrafish and to validate cluster identification by in situ hybridization. Commercially
available smFISH kits have recently become available, but our current fluorescence microscope is
insufficient for smFISH. In contrast, the Keyence fluorescence microscope can efficiently validate scRNA-
seq cell clusters by smFISH. It combines features of a formal microscope, a plate reader, a slide scanner,
and a confocal fluorescence microscope that will enable validation experiments on zebrafish not possible
with our current equipment.
Requested equipment will impact the full range of NIH Institutes and Centers because we perform
scRNA-seq and smFISH on intact animals encompassing all organ systems. Affected research fields
include genetics, developmental biology, cell biology, and pathology. The timeline for completion
includes immediate purchase of the microscope on award notification, delivery two weeks later, followed
directly by smFISH experiments. All funds will be spent in the current period. Requested equipment will
improve an important resource for animal models by localizing cell types in the body of a premiere animal
model of human disease, thus enhancing knowledge of cellular mechanisms in health and disease.

Public health relevance
Effective therapies with few side effects target specific molecules within unique cell types, but we lack a comprehensive understanding of human cell types and the genes they express. This project will exhaustively define cell types by their genome-wide gene expression patterns for embryonic, juvenile, and adult zebrafish, a medical model organism with a backbone that is readily manipulated for functional studies and possesses organs, tissues, cells, and genes that function like those in humans. This administrative supplement request is to fund the purchase of a Keyence fluorescence microscope to utilize single- molecule fluorescent in situ hybridization studies to identify precisely where cell types identified by the single cell transcriptomic studies reside in the vertebrate body. The project’s outcome will be the comprehensive characterization of cell types by the genes they express and the location of cell types in the body, and hence improve our understanding of cell function in human health and disease in ways that facilitate pathways to therapies.